Biomechanical Evaluation of a Novel, Compliant Low Profile Prosthetic Foot

PROJECT SUMMARY
While conventional wisdom holds that individuals with longer residual limbs retain greater function, they are
actually confined to low-profile feet that limit performance. In particular, low-profile feet are often much stiffer
than their standard profile counterparts. As such, many of the individuals with transtibial amputation that have
long residual limbs are unable to obtain prosthetic feet that adequately meet their needs.
This Phase I application describes a layered low-profile prosthetic foot for individuals with transtibial
amputation that can achieve an unprecedented level of compliance without sacrificing strength. As a result of
this novel design, preliminary work has shown energy storage and stiffness comparable to a standard height
prosthetic foot in a package just one third the build height.
The primary goal of this Phase I proposal is to conduct a multi-subject assessment of the value of the
proposed prosthesis both relative to a range of standard profile feet, and also relative to commercially available
low-profile feet. In order to do so, we propose the following aims: 1) design and test a family of layered low-
profile feet for users up to 100 kg with foot sizes from 22 to 28 cm, 2) assess the biomechanical benefits of the
layered low-profile foot with three transtibial prosthesis users with short residual limbs and three users with long
residual limbs during level ground walking, and 3) assess the biomechanical function of the layered low-profile
foot in a battery of activities of daily use.

Public health relevance
PROJECT NARRATIVE We have developed a novel layered low-profile prosthetic foot that is able to provide enhanced compliance without sacrificing strength for individuals with transtibial amputation who have long residual limbs. It is hypothesized that the proposed prosthesis will offer similar benefits to these individuals as comparable higher profile prostheses offer users with shorter residual limbs. The primary goal of this Phase I proposal is to assess the degree to which the proposed prosthesis can provide benefits to prosthesis users in this population, along with characterizing the degree to which the novel prosthesis emulates its taller counterparts.